Structural characterization of the elongasome and divisome in mycobacteria

Project Summary
Mycobacterium tuberculosis (Mtb), the causative agent of tuberculosis (TB), is one of the leading causes of death
due to infectious disease. Antibiotic treatment of Mtb is arduous and multidrug-resistant strains are on the rise,
thus fueling the need for novel therapeutics. During infection, subpopulations of Mtb cells are phenotypically
heterogeneous and can survive extensive chemical regimens, thus preventing the cure of disease. Cellular
heterogeneity arises from the asymmetric growth and division of the bacterium, resulting in daughter cells with
varying characteristics. As mycobacteria replicate, they must coordinate the division complex (divisome) and
elongation machinery (elongasome) spatially and temporally for proper cell division. These protein systems
share some similarities with the systems found in Escherichia coli and Bacillus subtilis, which grow and divide
symmetrically. However, mycobacteria lack several major elongasome and divisome components that are found
in these model bacteria, and components that are shared contain substantial N- and C-terminal expansions,
which may interact with other co-factors. Immunoprecipitation and light microscopy suggest that the
mycobacterial elongasome and divisome components potentially crosstalk with one another and form large multi-
subunit protein complexes. PonA1 and CrgA are critical proteins of both the elongasome and divisome and are
thought to make a multitude of interactions with other proteins in these systems. However, how these
components coordinate and interact to support asymmetric growth and division is not well understood at a
structural and mechanistic level. This proposal is focused on the biochemical and structural characterization of
the elongasome and divisome from Mtb and the non-pathogenic model mycobacterium, Mycobacterium
smegmatis. Bacterial genetics and endogenous protein purifications will be employed to purify PonA1, CrgA,
and their associated complexes directly from mycobacterial cells, and single-particle cryo-electron microscopy
will be used to determine their 3D structures (Aim 1). Novel proximity labeling will be utilized to define the protein-
protein interaction networks of divisome and elongasome components and to decipher the roles of their N- and
C-terminal expansions (Aim 2). Cutting-edge cryo-electron tomography will be implemented to capture 3D
snapshots of dividing mycobacteria to determine how the elongasome and divisome proteins are structured and
organized in situ (Aim 3). This proposal is innovative in that it applies emerging techniques to provide a more
complete picture of the protein complexes that constitute the elongasome and divisome and how they interact to
facilitate asymmetric growth and division in mycobacteria. This work will provide important insights into the
structures of these multi-protein complexes that can be used for the design of new therapeutics for TB.

Public health relevance
Project Narrative Mycobacterium tuberculosis (Mtb), the causative bacterial pathogen of tuberculosis, stands as the foremost contributor to mortality resulting from infectious diseases. On a cellular level, Mtb exhibits asymmetrical growth and division that lead to subpopulations of cells that can survive antibiotic therapy. We will study the protein systems that facilitate asymmetric growth and division in mycobacteria at the molecular and structural level, which may aid in the development of new antibiotics and therapies for tuberculosis.